Siglecs in the Porcine Oviduct: Roles in the Sperm Reservoir and Sperm Immune Response

Project Summary/Abstract
Siglecs in the Porcine Oviduct: Roles in the Formation of the Sperm Reservoir and Sperm Immune
Response
In mammals, only a small fraction of the deposited spermatozoa in the female reproductive tract reach
the oviduct. Once in the oviduct, sperm bind to the oviductal epithelium, forming the functional sperm reservoir,
which is crucial in prolonging sperm lifespan by inducing sperm into a quiescent state and providing these
foreign gametes with an immune-suppressed environment. Siglecs are immunomodulatory receptors that
recognize sialic acid-containing glycoconjugates. Using the pig as a model, we have discovered the presence
of up to eight different Siglecs in the porcine oviduct, five of which are immune inhibitory. We have also
characterized the N- and O-glycans and glycolipids present in porcine spermatozoa. Our results have identified
the presence of several sialic acid-containing glycoconjugates on porcine sperm that are ligands for Siglecs.
We hypothesize that the interactions of sialylated glycans of sperm with Siglecs from the oviduct are essential
for sperm adhesion to the epithelium and sperm survival by suppressing leukocyte infiltration and the local
innate immune response. The overall goal of this study is to develop a clear understanding of the role of
Siglecs in the oviduct and sperm sialic acids during the formation of the sperm reservoir. The Specific Aims are
1) to determine the cellular location and abundance of Siglecs in the oviduct epithelium and sialic acid
terminating glycans on sperm, 2) to determine the role of Siglec-1 and other Siglecs in sperm adhesion to
oviduct cells, and 3) to determine the role of oviduct Siglecs in local immune regulation upon sperm-oviduct
interactions. To address these aims I will utilize a combination of biochemical, cell and molecular, biological,
and genomic approaches along with both in-vitro and in-vivo models. The findings from this study have
practical applications such as enhanced diagnosis of idiopathic infertility and the development of novel
approaches to regulating fertility such as the discovery of new contraceptive targets.
This research training plan will provide me with training in a variety of cutting-edge and foundational
techniques using an interdisciplinary approach that includes reproduction, immunology, and glycobiology.
Moreover, it will support opportunities for career development to prepare me for a successful career in science.
The outstanding scientific environment of the University of Illinois will provide me with multiple learning
opportunities and the resources to accomplish this study. Dr. Miller, with proven mentoring experience and
expertise in the study of the sperm-oviduct interaction, as well as my co-sponsors Dr. McKim and Dr. Nowak,
will guide me in the success of the proposed research training plan and my scientific career development.

Public health relevance
Project Narrative Cells lining the lower part of the oviduct retain sperm to form a reservoir before fertilization. The goal of this study is to define how complex sugars on the sperm surface and newly-discovered Siglec proteins in the reservoir surface contribute to sperm adhesion and regulation of the local immune system. The long-term outcome of our findings could result in the development of novel contraceptive targets and help us understand some of the causes of idiopathic infertility.